Sensory-Targeted Ankle Rehabilitation Strategies (STARS)

DESCRIPTION (provided by applicant): Injury associated with sport and recreation is a leading reason for physical activity cessation, which is linked with significant long-term negative sequelae. Ankle sprains are the most common injuries associated with physical activity and at least 1 out of every 3 individuals who sprain their ankle will go on to develop chronic ankle instability (CAI), defined by life-long residual symptoms including decreased physical activity. Traditional rehabilitation strategies for CAI have focus on motor impairments, but the high incidence of disability, post- traumatic ankle osteoarthritis, and consequent healthcare burdens clearly indicate that this treatment model is ineffective. Thus, a pressing need exists for a paradigm shift in the development of effective evidenced-based interventions to treat CAI. To date, little attention has been paid to the potential to improve function by intervening through sensory pathways. Research, has shown that the sensorimotor system shifts reliance on various sensory inputs depending on the demands placed on the system. Those with CAI place a greater emphasis on cutaneous and musculotendinous receptors due to damage of the lateral ankle joint receptors. However, by using sensory-targeted ankle rehabilitation strategies such as ankle joint mobilizations, plantar massage, and triceps surae stretching, we hypothesize that we can enhance the information available to the sensorimotor system in order to tune effective movement solutions. Indeed, our evidence suggests that sensory-targeted strategies may be essential to most effectively treating those with CAI. Therefore, the purpose of this proposal is to determine the effectiveness of sensory-targeted ankle rehabilitation strategies at causing immediate and prolonged improvements in subjective and objective outcome measures of clinical disablement and sensorimotor dysfunction in those with CAI. This preliminary investigation will be a randomized controlled trial in which 80 subjects with CAI will be randomly assigned to receive one of three experimental interventions (mobilization, massage, stretch) or a control treatment. To evaluate the effects of the experimental treatments, the following baseline measures will be taken: 1) self-assessed disability, 2) ankle dorsiflexion range of motion, and 3) sensorimotor function via measures of postural control and gait initiation. Subjects will then be randomly assigned to receive ankle mobilization (n=20), plantar massage (n=20), triceps surae stretching (n=20), or a control treatment (n=20). Follow up measures will be taken immediately after the first and final treatment of a two-week intervention as well as 1-month after receiving the treatment intervention. For this investigation, separate MANOVAs will assess the effects of treatment (mobilization, massage, stretch, control) and time (baseline, post 1st treatment, post final treatment, 1-month follow-up) on subjective and objective measures of clinical disablement and sensorimotor function in those with CAI. The results of this randomized controlled study will elucidate the effectiveness of sensory-targeted ankle rehabilitation strategies at improving sensorimotor function and disability in those with CAI.

Public health relevance
PUBLIC HEALTH RELEVANCE:: Ankle sprains are the most common injury experienced by those who are physically active and recurrent disability associated with these injuries is extremely common. In this study, we aim to determine the benefits of sensory-targeted ankle rehabilitation strategies on subjective and objective outcomes of clinical disablement and sensorimotor function in those with chronic ankle instability. By developing new sensory-targeted strategies for this pervasive condition, we hope to optimize treatment efficiency and quality for patients with chronic ankle instability and subsequently reduce their associated long-term negative sequelae and disability. : Ankle sprains are the most common injury experienced by those who are physically active and recurrent disability associated with these injuries is extremely common. In this study, we aim to determine the benefits of sensory-targeted ankle rehabilitation strategies on subjective and objective outcomes of clinical disablement and sensorimotor function in those with chronic ankle instability. By developing new sensory-targeted strategies for this pervasive condition, we hope to optimize treatment efficiency and quality for patients with chronic ankle instability and subsequently reduce their associated long-term negative sequelae and disability. __SpecificAimsTextDelimiter__ 2. SPECIFC AIMS: Lower extremity injury is a leading reason that people stop participating in physical activity. Decreased physical activity results in a decreased quality of life, and significant long-term negative sequelae including obesity.1 Lateral ankle sprains are the most common injury (~25,000 daily) suffered during physical activity2-4 and represent a significant public health problem. Up to 75% of individuals who sprain their ankle subsequently develop chronic ankle instability (CAI); characterized by life-long residual symptoms,5 recurrent injury,6 and decreased physical activity.7 More importantly, as many as 78% of those with CAI develop post- traumatic ankle osteoarthritis.8, 9 CAI is a health condition that significantly constrains the sensorimotor system's ability to cope with changing task and environmental demands, resulting in repeated ankle sprains.10, 11 Traditional rehabilitation strategies for this condition focus on motor pathway impairments (i.e. strength, coordination) with very little emphasis on the potential to intervene through sensory pathways. Similarly, most research on CAI has focused only on maximizing motor output, ignoring the full spectrum of sensorimotor dysfunction associated with CAI. However, it has been demonstrated that the sensorimotor system dynamically shifts reliance on various sensory inputs depending on the demands placed on the system.12 In the case of CAI, damaged ankle joint receptors may constrain the sensory information available to the system, with significant functional consequences. Constraining ankle articular receptor information from healthy individuals has deleterious effects on postural control.13 Further, stimulation of other ankle joint receptors through a single treatment of ankle joint mobilizations significantly improves postural control in those with CAI.14 Additionally, those with CAI rely more heavily on plantar cutaneous receptors and musculotendinous receptors of the triceps surae due to the absent or inappropriate information from the lateral ankle receptors.15 Based on this evidence, there exists the opportunity to advantageously focus on these sensory inputs through sensory-targeted strategies to effectively rehabilitate CAI. In fact, our evidence14, 16, 17 suggests that sensory-targeted ankle rehabilitation strategies, based on the dynamic regulation of sensory inputs, may be essential to most effectively treat those with CAI. Our preliminary data suggest that 2 weeks of sensory-targeted ankle rehabilitation strategies, including triceps surae stretching, plantar massage, or ankle joint mobilization, targeting 3 types of sensory pathways (musculotendinous, plantar cutaneous, and articular, respectively), has beneficial effects on both subjective and objective measures of sensorimotor function in those with CAI. However, we do not yet understand the unique contributions of these interventions. The goal of this research proposal is to determine the effectiveness of sensory-targeted ankle rehabilitation strategies at causing immediate and prolonged improvements in subjective and objective outcome measures of clinical disablement and sensorimotor dysfunction in those with CAI. We hypothesize that sensory-targeted ankle rehabilitation strategies directed to each of the three sources of sensory input will result in specific and unique improvements in sensorimotor system function. We will test this hypothesis by evaluating the impact of two weeks of sensory-targeted ankle rehabilitation strategies on CAI through completion of the following two specific aims: Aim 1: Quantify subjective measures of disability including self-reported function on activities of daily living, activities of sport, and episodes of instability. We will quantify changes in the Foot and Ankle Ability Measure (FAAM) subscales and the number of self- reported giving way episodes immediately and 1-month after a two-week intervention. Aim 2: Quantify objective measures of sensorimotor function including dorsiflexion range of motion (ROM), postural control, and gait initiation. We will quantify changes in weight-bearing dorsiflexion ROM, postural control (Time-to-Boundary, Balance Error Scoring System), and gait initiation (Center-of-Pressure excursions) after the first and final treatment and 1-month after a two-week intervention. Based on our preliminary data, we anticipate finding that all three strategies will improve subjective function, but each will have unique influences on the objective measures of sensorimotor function. Relationships found from completion of Aims 1 and 2 will provide us with a holistic perspective in the evaluation of sensory-targeted ankle rehabilitation strategies as effective treatments for CAI. From this study, our long-term goal of developing effective sensorimotor interventions for CAI will be advanced. Low-cost, easily implemented sensory-targeted interventions will be the foundation for optimizing the efficacy, quality, and cost associated with treating patients with CAI. The innovation of this proposal is grounded in our novel approach (sensory-targeted interventions) and the combined use of validated subjective and objective outcomes measures shown to detect sensorimotor alterations in CAI.